Investigating the role of FGF21 in bone homeostasis in Duchenne Muscular Dystrophy

PROJECT SUMMARY/ABSTRACT
Duchenne Muscular Dystrophy (DMD) is a severe muscle-wasting disease caused by mutations in the
dystrophin gene (DMD). Beyond the characteristic muscle wasting, patients with DMD are often plagued by
significant skeletal comorbidities, including severe osteoporosis and consequent fracture. Although an
estimated 60% of patients are affected by these comorbidities, there are no recommended prophylactic
treatments. This is partially due to poor understanding of the pathogenesis of osteoporosis in DMD.
Osteoporosis results when bone resorption by osteoclasts outweighs bone deposition by osteoblasts. Our lab
has identified a novel myokine, fibroblast growth factor 21 (FGF21), which is increased in the serum of DMD
patients and mouse models. Neutralization of FGF21 prevented osteoporosis in a mouse model by reducing
the number of osteoclasts. Furthermore, in vitro studies demonstrated that FGF21 directly promotes
osteoclastogenesis. However, the mechanism of FGF21 signaling to osteoclasts remains unknown. Aim 1 will
investigate the role of FGF21 signaling to osteoclasts in bone homeostasis in a mouse model of DMD by using
osteoclast-specific FGF21 receptor knockout mice. Aim 2 will explore how FGF21 potentiates
osteoclastogenesis by evaluating signaling mechanisms and the effect on precursor fusion, an essential step in
differentiation. Since preliminary data also suggest that FGF21 promotes osteoclast activity, Aim 3 will examine
how FGF21 affects secretion of bone-resorptive proteins via the lysosome. These carefully and rigorously
designed studies will provide valuable insight into how FGF21 promotes osteoporosis in DMD and advance our
understanding of osteoclast biology. Successful completion of this project will establish FGF21 as a critical
regulator of bone homeostasis and a promising target for treatment of osteoporosis in this patient population.
The project and training plan described herein were developed specifically for Ms. Hurley-Novatny. The
experiences, skills, mentoring, and topics of this proposal were designed to ensure that Ms. Hurley-Novatny
achieves her training goals and becomes a successful, independent physician-scientist in the field of
orthopedics and bone research. Under the guidance of Dr. Hongshuai Li and Dr. Matthew Potthoff, Ms. Hurley-
Novatny will receive the mentorship she needs to develop as a scientist and the technical training to become a
researcher in musculoskeletal biology. The MSTP, Department of Orthopedics, and Department of Anatomy
and Cell Biology provide ample training opportunities in the form of seminars, collaborations, opportunities to
present research, and research support both financially and otherwise. The University of Iowa has an
unparalleled history of research in the field of orthopedics, providing Ms. Hurley-Novatny a unique training
environment to achieve her goal of becoming a surgeon-scientist in the field of orthopedics at a major
academic medical center.

Public health relevance
PROJECT NARRATIVE Osteoporosis and fragility fractures affect 60% of patients with Duchenne Muscular Dystrophy (DMD) within their second decade of life, yet there are no treatments to address this issue. This project will investigate the role of fibroblast growth factor 21 (FGF21) in the pathogenesis of DMD-related osteoporosis. Our findings will provide an improved understanding of the factors affecting osteoporosis in DMD and provide evidence for future clinical trials targeting FGF21 to prevent bone loss in this patient population.